BLRD Research Career Scientist Award Application

Project Summary/Abstract
Dr Madabhushi has emerged as a pioneer in the development and application of novel and interpretable Artificial
Intelligence (AI) algorithms for disease diagnosis, prognosis and prediction of treatment response for a variety
of diseases including several cancers, cardiovascular, kidney and eye disease. Veterans, in many cases on
account of their exposure to wartime environments and particular lifestyle choices, engenders different disease
phenotypes compared to the civilian population. Over the last three years he has been optimizing and tailoring
AI tools to addressing problems in precision medicine for Veterans. While his primary focus has been on
diagnosis, prognosis and prediction of treatment response of lung, oropharyngeal, breast and prostate cancers
for the Veteran population, he is also focused on translating and deploying these clinical decision support tools
across VA stations and VISNs so that Veterans can experience precision medicine across different diseases.
Dr Madabhushi's research within the VA began in 2019 with a VA Merit award (I01BX004121) focused on AI
based lung cancer screening for VA patients, specifically helping to discriminate malignant from benign nodules
on routine CT scans. This work has led to development of AI driven imaging biomarkers for predicting response
to immunotherapy for lung cancer patients. More recently in a paper just published in the J of Immunotherapy
for Cancer1, Dr. Madabhushi's group demonstrated the utility of radiomics on CT scans to identify clinical
outcome for Stage III lung cancer patients treated with chemo-radiation therapy and immunotherapy.
Interestingly, the work showed that a subset of patients identified by his AI-based approach might be able to
avoid chemo-radiation therapy and hence the associated toxicity. The study included a cohort of 15 patients from
the Cleveland VA. Similarly, his team has been developing and applying AI tools both for digital pathology as
well as on radiology scans for risk stratification of oropharyngeal cancers within the VA. This work was achieved
through collaboration with Vlad Sandulache at the Houston VA and with Stephen Connelly at the San Francisco
VA that has resulted in a series of high impact manuscripts (J of NCI, J of Clinical Investigation, Modern
Pathology) and an NCI funded R01 (R01CA249992).
In order to expand his work and footprint within the VA, he and his team have received funding support (in 2021)
from the Cooperative Services Program to create a VA Hub for Computer Vision and Machine Learning in
Precision Oncology (CoMPL). This new VA Hub will create computer vision and machine learning (CVML) tools
for addressing cancer diagnosis, prognosis, risk stratification and prediction of treatment response in the VA
population. The objectives of CoMPL are: 1) focus on building the computational infrastructure and tools to allow
for expanding the scope and access to CVML resources within the VA, and building a community to enable VA
researchers to take advantage of these tools to develop their own CVML applications; and 2) to develop new
companion diagnostic tools for risk assessment, predicting response and need for more or less aggressive
therapy in prostate and lung cancer. An initial demonstration project of CoMPL will focus on application of AI
tools with CT scans and digital pathology images to identify benefit of adjuvant chemotherapy in early-stage
Veteran lung cancer patients. Dr. Madabhushi's is also leading a new prostate cancer collaborative involving
urologists, radiologists and oncologists from multiple different VA stations and VISNs to develop the use of AI
with multimodal imaging (MRI and digital pathology) along with genomics for more accurate risk stratification of
Veterans with high-risk prostate cancer. The CoMPL team is partnering with the National Artificial Intelligence
Institute (NAII), Lung Cancer Precision Oncology (LPOP) and Precision Oncology Program for Cancer of the
Prostate (POPCaP) centers to enable dissemination of the decision support tools and the deeply annotated
digital pathology and radiology scans that result from CoMPL's activities.

Public health relevance
Project Narrative: Dr Madabhushi's pioneering work on artificial intelligence (AI) has enabled the development of decision support tools to aid clinicians in treating patients suffering from a variety of cancers (breast, prostate, lung, head and neck), but also cardiovascular, kidney and eye disease. Most recently his group adapted AI and radiomics technologies developed for their VA merit project on lung cancer screening for Veterans to digitally analyze CT scans to identify the severity of COVID19 disease. His work has recently focused on the use of AI to help eliminate racial disparities in medicine by identifying disease patterns that might be specific to certain populations, in turn enabling development of population-specific personalized risk calculators. He is applying this AI approach to disease diagnosis, risk stratification, outcome and treatment response prediction in Veterans, where their unique exposure to wartime environments and particular lifestyle choices, engenders different disease phenotypes compared to the civilian population.